Determinants of Usutu virus bird-to-mosquito transmission

Project Summary
West Nile virus (WNV), St. Louis encephalitis virus (SLEV), and Usutu virus (USUV) are closely-related
mosquito-borne viruses that cause neuroinvasive disease in humans. All three viruses are maintained in
overlapping bird/mosquito cycles, with spillover to humans. The introduction of WNV into the U.S. in 1999
quickly displaced the previously-circulating SLEV due to cross-reactive immune responses in birds. However, a
novel genotype of SLEV recently emerged in the U.S., causing an outbreak in 2015, and we have found that
WNV immune responses in birds do not neutralize the novel SLEV genotype in vitro. USUV recently emerged
in Europe, where it has been introduced at least three times from Africa. We have found that House sparrows
(Passer domesticus) and Culex quinquefasciatus mosquitoes, which are competent for WNV and SLEV, are
also susceptible to USUV. The long-term goal of this project is to understand the factors that influence novel
flavivirus emergence in order to predict outbreaks in humans. The objectives of this study are to identify
competent North American avian and mosquito species for USUV and to determine the role of WNV immunity
in birds on SLEV and USUV emergence. The hypothesis is that the novel SLEV genotype and USUV have
established or have the potential to establish transmission cycles in North America due to the competence of
local birds and mosquitoes and the evasion of WNV immunity in birds, thus leading to an increased risk of
neuroinvasive disease in humans. Two specific aims will address this hypothesis: 1) Determine whether North
American passerines and mosquitoes are competent for USUV; and 2) Assess the influence of previous
exposure to WNV on SLEV and USUV infection in birds. In the first aim, we will trap three species of wild birds
to determine the susceptibility of local birds to USUV. We will quantify the infectious threshold of USUV for
bird-to-mosquito transmission by feeding mosquitoes on infected birds and then measure infectious virus in the
expectorate of infected mosquitoes. In the second aim, the effect of WNV pre-exposure on subsequent
infection by the novel SLEV genotype and USUV will be evaluated in birds. Sera from inoculated birds will be
tested for in vitro neutralizing activity against all three viruses to determine the capacity for diagnostically
identifying flavivirus infections using serology. The research proposed here is innovative because it
investigates a novel SLEV genotype and USUV, which are neglected, emerging viruses, using a novel avian
experimental model. Upon successful completion of the proposed research, the anticipated contribution of this
work will be the identification of USUV reservoir and vector species and factors that influence enzootic
transmission of SLEV and USUV. This contribution is expected to be significant because understanding the
transmission cycle of emerging flaviviruses will lead to the ability to predict disease in humans.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will investigate the transmission cycle of St. Louis encephalitis virus (SLEV) and Usutu virus (USUV), which are neglected, emerging arboviruses that cause neuroinvasive disease in humans. By identifying North American bird and mosquito species that are competent for USUV transmission and identifying factors that alter SLEV transmission, this work will lead to the ability to predict neuroinvasive disease in humans.